Modeling Social and Non-Social Learning in Autism

PROJECT SUMMARY/ABSTRACT
Advances in genetics, molecular biology, and cognitive neuroscience offer promise towards personalized
treatment and improved outcomes in individuals with Autism Spectrum Disorder (ASD). However, the promise
of precision medicine has been hindered by a lack of mechanistic models that explain phenotypic and etiological
heterogeneity; instead of using such models to identify subgroups likely to respond to specific treatments, the
field relies on availability of service, trial-and-error, and clinical judgment to make treatment decisions. This is a
major barrier to effective treatment of ASD. This project addresses this problem by integrating mathematical
models of behavior and brain activity across adolescent development, in order to establish a neurocognitive
model that can successfully predict individual adolescents' social and nonsocial learning profiles at key
developmental time-points. Specifically, this work compares the suitability of various reinforcement learning
models to capture selective deficits in social learning of adolescents with ASD, as well as variability in both social
and nonsocial learning across typically developing (TD) adolescents and those with ASD. Identifying how these
model-based predictions are implemented in brain circuits may allow for characterization of the neural
architecture underlying learning in therapeutically relevant contexts. This project focuses on the understudied
role of the cerebellar posterior lobe in learning processes of interest, given recent research indicating this region's
involvement in updating social information. The proposed work will identify and characterize neurocognitive
variability in the substrates of learning within ASD, with the long-term goal of applying these models to inform,
refine, and individualize diagnosis, prognosis, education, and treatment of youth with ASD.

Public health relevance
PROJECT NARRATIVE This project examines the brain mechanisms of learning in adolescents with autism spectrum disorder (ASD), focusing on a region of the brain, the cerebellum, that is known among neurotypical individuals to be important for making predictions and reducing errors, and which shows evidence of atypical development in ASD. This work may help us understand the brain processes related to the difficulties that individuals with ASD often have in learning about the social world, as well as other common symptoms of ASD, such as difficulties generalizing learned behaviors and insistence on sameness. It may also help us develop individual learning profiles for youth with ASD that may allow for educators and therapists to make better-informed decisions about treatment plans for a specific individual.